Transgenic analysis of glutamate in sensitization

DESCRIPTION (provided by applicant): Psychostimulants act by increasing synaptic dopamine levels, principally in the nucleus accumbens. When taken repeatedly, constant psychostimulant doses produce an increasing behavioral response - known as psychostimulant sensitization. This animal model of drug dependence is mediated by neuroplastic changes both at the level of the dopamine neuron cell bodies in the ventral tegmental area and a their synapses in the nucleus accumbens. These changes require glutamatergic synaptic transmission. Recently, this laboratory has made the striking observation that dopamine neurons corelease glutamate. If so, glutamatergic synapses of dopamine neurons are likely to be important in sensitization. To test this, mice generated in this laboratory with fluorescent dopamine neurons will be used to examine the relationship between the dopaminergic ami glutamatergic terminals of single dopamine neurons and to assess the plastic capabilities of the glutamatergic synapses as a basis for sensitization. To address the role of the glutamatergic cotransmission in the behaving animal, another line of mice have been made that lack glutaminase - the enzyme principally responsible for Ihe production of neurotransmitter glutamate. Preliminary results confirming the importance of glutaminase will be extended to test this definitively. Interestingly, mice heterozygous for glutaminase appear to be already in a sensitized state, as they show an exaggerated response to stimulants. Using tissue-specific rescue and deletion approaches, the final aim is to identify the crucial glutamatergic circuits underlying the sensitized phenotype. Finally, the role of glutamatergic cotransmission by dopamine neurons in the development of sensitization will be tested in mice lacking glutaminase in their dopamine neurons. This integrated approach should help to elucidate the crucial glutamatergic circuits underlying sensitization, and offer new targets lor the pharmacological reduction of sensitization and thus of drug dependence.